Cancer Biology Training Program

DESCRIPTION (provided by applicant): This is a new application for a Cancer Biology Training Program at Indiana University School of Medicine which is located on the Indiana University Purdue University at Indianapolis campus. The goal of the Program is to produce postdoctoral and predoctoral trainees who have experienced an interdisciplinary environment of interacting basic scientists and clinicians committed to cancer research. Strengths of the Program include the quality of the preceptors and environment and the diversity of cancer research. The twenty-seven preceptors are members of the Indiana University Cancer Center and the Indiana University Graduate School. They have primary or secondary appointments in the Departments of Biochemistry and Molecular Biology, Cellular and Integrative Physiology, Medical and Molecular Genetics, Microbiology and Immunology, and Pharmacology and Toxicology. Several also have primary appointments in Medicine, Obstetrics and Gynecology, Pediatrics, Surgery, or Urology. The preceptors are highly interactive, collaborating in both the research and teaching arenas. Support is requested for 6 postdoctoral and 2 predoctoral trainees. In addition to their research, postdoctoral and predoctoral trainees will participate in two weekly cancer seminar series: a basic science series and Grand Rounds. For one year each, the trainees will attend and present their research in a monthly meeting of the Regulation of Cell Growth Program and the Experimental Therapeutics Program of the Indiana University Cancer Center. Also, the trainees will present their research at the Indiana University Cancer Center Annual Cancer Research Day. All trainees will take a course in scientific ethics. Postdoctoral trainees will be Ph.D.s. recruited into individual laboratories or M.D.s participating in the clinical fellowship programs. Requirement of didactic coursework will be tailored to the particular background of the postdoctoral fellow. Predoctoral trainees will fulfill the requirements of their individual departments and complete a Cancer Biology Minor or equivalent coursework.